Expanding high-impact mentorship and research in the Bracht Laboratory

Abstract of Supplement: The proposed supplemental funding will be used to both expand
mentoring of a diverse student research group in the Bracht laboratory at American University, and
expand the research proposed in the parent grant (1R15GM146207). The parent grant abstract is
reproduced below; the supplemental research is within the scope of this parent grant.
Abstract of parent award: A critical and well-studied cellular stress response pathway, the
Unfolded Protein Response (UPR), protects organisms against several stressors including heat, hypoxia,
starvation, and toxins. Helping to repair cellular damage, the UPR can also trigger apoptosis if the stress
is ongoing, severe, and unrecoverable. Therefore, proper regulation of this pathway is essential,
particularly since its malfunction contributes to human pathologies including autoimmune disorders,
cancer, and neurodegenerative diseases. The Bracht lab recently published the genome of a nematode,
Halicephalobus mephisto, isolated from the deep terrestrial subsurface of South Africa, over a kilometer
underground. This organism has adapted to a stressful environment: hot, hypoxic, and rich in methane.
Therefore the organism displays a naturally evolved resilience to stresses that would normally cause
lethality; we also found that its UPR pathway is a site where adaptation has occurred. We have confirmed
that RNA Interference (RNAi) by feeding can be used to modulate gene expression in this organism,
setting the stage for a molecular investigation of stress resilience.
New supplemental aims:
Aim 1. Single-cell RNA-seq of ARMET RNAi in H. mephisto.
In the parent grant, we described a gene, Arginine-Rich, Mutated in Early-stage Tumors /
Mesencephalic Astrocyte derived Neurotrophic Factor (ARMET/MANF), that is highly expressed when
the nematodes are grown at high temperatures. Surprisingly, our RNAseq data have uncovered an
exciting and previously unknown link between the UPR pathway and insulin signaling. We propose to
perform single-cell sequencing to identify which tissues are implicated in this process.
Aim 2. Analysis of a more efficient mitochondrial proton pump in H. mephisto.
In this aim we extend the research into H. mephisto adaptation into hypoxia, an environmental stress
described in the parent grant. We found that the mitochondrial genome of H. mephisto exhibits an altered
proton pump in the cytochrome c oxidase complex. We show that this pump is more effective than that
encoded by C. elegans, a standard laboratory nematode, non-hypoxia adapted worm. We propose to
perform extensive metabolic analysis of H. mephisto to confirm and extend these findings to whole-
organism physiology.

Public health relevance
This proposal explores the unique evolutionary adaptation of a nematode (roundworm) isolated from deep underground in a South African goldmine, whose genome has adapted to enable it to survive environmental stress. The pathway involved, the unfolded protein response (UPR), is also involved in human pathologies including neurodegeneration, cancer, and autoimmune disease. Thus, understanding the principles of adaptation in this organism may suggest new ways of treating these human diseases.